Molecular Basis of Lipid-linked Sugar Transfer

Project Summary
The majority of synthesized proteins undergo glycosylation, a process by which a carbohydrate, or glycan, is
attached onto the protein surface serving both structural and functional roles. Proper glycosylation in the lumen
of the endoplasmic reticulum requires membrane accessible sugars, primarily mannose, in order to synthesize
complex, branched oligosaccharides for transfer onto nascent peptides. To traffic sugars along the membrane,
they must be transferred onto lipid polyprenyl carriers, namely dolichol phosphate. The synthesis of these
mannose glycosyl carriers by the Dolichol Phosphate Mannose 1 (DPM1) represents the primarily mechanism
of glycosyl donor biosynthesis, a pathway that is subsequently disrupted in severe types of Continental Disorders
of Glycosylation (CDGs). Since sugars play a critical role in folding, stability, and affect the function of numerous
proteins across several organ systems, DPM1 causing CDGs result in severe development delays, seizures,
liver disease, and neuromuscular impairment. The molecule mechanism of DPM1 remains unsolved, largely due
to a lack of structural information about its interaction with both the sugar and polyprenyl substrate which need
to be mediated towards an active site that lies just outside the membrane. Existing structural studies have
focused on a bacterial enzyme homolog, GtrB, which provides a model for understanding DPM1 and CDG.
Although GtrB has been structurally characterized, significant questions remain about the binding sites and
conformational changes required for its enzymatic activity. Specifically, we lack a model by which a hydrophobic
polyprenyl carrier is brought into proximity to the cytosolic sugar substrate and if a conformational change is
needed within the membrane region of GtrB. Here, we propose a time-resolved cryo-EM approach to study the
enzymatic states of GtrB catalysis. The approach involves a 'flash and freeze' system using chemically-caged
substrates to rapidly initiate enzyme activity during sample preparation with UV light. This method is designed to
overcome the limitations of traditional cryo-EM in capturing transient and high-energy states. By applying this
technique, the project will identify and analyze various structural states of GtrB, including its holo, intermediate,
and product-bound forms, thereby providing a detailed model of glycolipid biosynthesis. The collected model will
be integrated with molecular dynamics to provide a holistic model of catalysis that is experimentally and
computationally validated. We observe that to mediate polyprenyl coordination, there is a major shift in two
peripheral membrane helices in order to lower the lipid carrier into the cytosolic active site. Several mutations in
DPM1 that cause CDG can be mapped to this region, indicating a conserved mechanism critical for product
formation. We will investigate the kinetic effects of these mutations by monitoring the rate of product formation
in a native-liposome environment. Through these investigations, the project aims to enhance our understanding
of glycosylation and its disruption in genetic disorders.

Public health relevance
Project Narrative The process of sugar attachment to the surface of proteins, or glycosylation, is ubiquitous to cellular function, representing a major functional pathway that is disrupted in diseases known as Congenital Disorders of Glycosylation (CDG). To understand the molecular mechanism of how sugar is transferred onto membrane carriers, we utilize a bacterial model for CDG and a novel structural method that captures an ensemble of high- resolution enzymatic states over time. We aim to provide a structural understanding that has been rarely observed and use biochemical studies to provide a complete understanding of glycosylation in both healthy and diseased individuals.